Structure and mechanism of pendrin and the mutations that cause Pendred's Syndrome

Pendrin (SLC26A4) is expressed in epithelial tissues, e.g., in the inner ear, thyroid, kidney, and lung where it
plays a central role in ion homeostasis and the regulation of the cell volume. Mutations in the Slc26a4 gene
cause Pendred Syndrome and enlarged vestibular aqueduct syndrome (EVAS), both of which are genetic
disorders characterized by childhood early hearing loss in children and account for 5-10% of hereditary hearing
loss and are currently not curable. Previous studies illuminated the role of pendrin in the physiology of the
cochlea, thyroid gland, kidney and proposed that it can transport iodide ions (I-), bicarbonate ions (HCO3-),
chloride ions (Cl-), and hydroxide ions (OH-) across epithelial cell membranes according to an electroneutral
exchange (antiport) reaction. However, our understanding of pendrin remains rudimentary due to a lack of
purified protein that enables precise functional studies without the potential interference of native proteins replete
in cellular/native systems and structural studies. To overcome this gap in our understanding, we have
successfully expressed and purified a mammalian homolog of human pendrin and developed binding and
transport assays to determine substrate selectivity and transport. Preliminary studies confirmed that purified
pendrin reconstituted in lipid membranes transports I- or HCO3- in exchange with Cl- or OH- and revealed that
the transport process is electrogenic, i.e., the stoichiometry of ion exchange is not 1:1 as previously postulated
for electroneutral antiport. We determined I-- and HCO3--bound pendrin structures by cryo-electron microscopy,
and our preliminary analysis suggests that pendrin has two anion binding sites, which may provide an explanation
for the electrogenic transport process. The structure reveals novel interactions between the transmembrane
domain (TMD) and the cytosolic domain, i.e., the sulphate transporter and anti-sigma factor antagonist domain
(STAS) that appears to be relevant for the transport mechanism because mutations at the interface of STAS and
TMD are known to cause Pendred Syndrome. Pendrin is also a promising drug target for attenuating airway
hyperresponsiveness in asthma and for reducing hypertension, and many pendrin inhibitors, e.g., the non-
steroidal anti-inflammatory drug niflumic acid, has been reported to target pendrin, but the mechanisms of
inhibition remain unknown. Whereas these inhibitors could be repurposed to target pendrin, their action on
pendrin may also cause undesired side-effects, thus highlighting the need to elucidate the mechanisms of
pendrin inhibition by small molecules. We determined the structures of pendrin in complex with the anti-
inflammatory drugs YS-01 and niflumic acid, and our preliminary analysis shows that the two inhibitors occupy
different binding sites, providing motivation for the further determination of the mechanisms of inhibition. To this
end, the overall goal of this project is to understand the mechanism and pharmacology of pendrin at the atomic
level to aid in the development of efficacious drugs that specifically target pendrin in improved therapies against
Pendred Syndrome and EVAS.

Public health relevance
Pendrin (SLC26A4) is an anion transporter that is expressed in epithelial cells, e.g., in the inner ear, thyroid, kidney, and lung where it plays a central role in ion homeostasis, and it is the molecular target of the non-steroidal anti-inflammatory drug niflumic acid. Mutations in the Slc26a4 gene cause Pendred Syndrome and Enlarged Vestibular Aqueduct Syndrome (EVAS), both of which are genetic disorders characterized by early hearing loss in children and account for 5-10% of hereditary hearing loss. The physiology and pathophysiology of pendrin is poorly understood, and this project, by using structural studies in conjunction with advanced transport and binding studies, seeks to elucidate the mechanism and pharmacology of pendrin at atomic level to aid in the development of efficacious therapies.